Continuous liquid-liquid extractors for doubling of productivity and henhancement of batch based drug manufacturing

Project Summary/Abstract
Domestic pharmaceutical manufacturing is struggling to meet demands. It is therefore
imperative to develop tools to rapidly increase the productivity of existing production plants.
Manufacturing of pharmaceuticals currently relies almost entirely on batch-based chemical
synthesis. In this approach, chemical synthesis takes place in several separate steps within
large reactors. Synthesis in continuous flow (with chemicals flowing continuously during the
reaction process) is emerging as a more efficient alternative. However, synthesis in continuous
flow is not being widely adopted due to several practical reasons, including the need for major
investments to overhaul existing production plants.
Liquid-liquid extraction (LLE) represents the most frequent post-reaction step in pharmaceutical
syntheses. Importantly, while technologies currently used for LLE in the context of batch
synthesis are a bottleneck that dramatically reduces process efficiency, LLE extraction in
continuous flow is highly efficient. Existing technologies for LLE in flow cannot currently be used
in batch-based manufacturing plants because their maximum flow rate is too low to meet the
demands of batch-based production plants.
Here, we propose to develop a novel, high capacity system to implement LLE in continuous flow
in the context of batch-based pharmaceutical synthesis. We envision a plug and play, portable,
high flow rate, self-tuning device deployable in existing pharmaceutical production plants without
the need to overhaul production processes. To build this system, in the Phase I of this SBIR, we
have addressed the key technological innovations needed to enable the proposed innovation. In
Phase II we are planning to demonstrated scalability of the Phase I findings; develop a suitable
packaging approach for low cost, chemically resistant separation modules; build and test in a
plant facility a complete, user-friendly high capacity continuous LLE system compatible with
large-scale batch-based pharmaceutical production.
If successful, this project will produce a tool able to immediately increase the productivity of
existing pharmaceutical plants from 2 to 5-fold. This product will redefine the landscape of
pharmaceutical production in the United States and beyond.

Public health relevance
Project Narrative Current pharmaceutical manufacturing is struggling to meet demands. A major bottleneck of modern pharmaceutical production is liquid-liquid extraction. Here, we propose the development of a new tool for liquid-liquid extraction that is expected to swiftly increase the productivity of existing pharmaceutical manufacturing plants 2 to 5-fold without the need for process overhaul.